ANGIOGRAPHY WITH THE ASPECT SYSTEM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. LS174T-e265 colorectal tumors will be implanted on the animal's right flank. Animals will be imaged every other day for 2 weeks. Purpose: To collect angiogenesis data using the Aspect MR system. The mice will be injected with the Gd Liposome in the morning and scanned during the day using a GRE sequence with ultrashort TE and TR. Images will be aquired on the 7T for comparison. Some images will be acquired using a surface coil to improve SNR. MIPs will be created after the study.